Dissemination and Implementation for Community Engagement

The Dissemination, Implementation, and Community Engagement (DICE) Core recognizes the transformative
potential of well-equipped and multidisciplinary teams of scholars, scientists, and clinicians collaborating with
patients, advocates, and communities to drive meaningful and sustained progress in addressing rheumatic
and musculoskeletal disease (RMDs), both in the region and nationally. Led by a strong multi-disciplinary team
with expertise in D&I science, community engagement, research recruitment, virtual/digital, and other novel
strategies, the DICE Core will endeavor to make notable strides towards enhancing health outcomes for RMD
patients by pursuing the following aims:
Specific Aim 1: To Facilitate the Recruitment of Patients Living with RMDs for BIGDATA Research
Projects. The DICE Core will aid in the adoption and implementation of evidence-based innovative strategies
for engagement across all populations, ensuring their meaningful participation in RMD research studies. Via
hybrid engagement methods, including online communities and registries, social media campaigns, and direct to-patient recruitment approaches, DICE will promote patient-centered research broadly.
Specific Aim 2. To Provide Comprehensive and Innovative Resources to the BIGDATA Research
Community in Dissemination and Implementation (D&I) Science. We will offer comprehensive consultation
and support to RMD researchers enabling them to effectively test interventions to implement, de-implement,
and disseminate evidence-based interventions to improve outcomes for people living with RMD. Consultations
will build on expertise in patient D&I theory, patient navigation, and training/ enrichment. These offerings will
equip researchers with the knowledge and skills necessary to translate RMD research discoveries into
practice.
Specific Aim 3. To Community Engagement in Recruitment, Dissemination, Implementation and in
other BIGDATA Research. In this cross-cutting aim, the DICE Core will function as a conduit for enabling
bidirectional communication between RMD researchers and RMD communities by leveraging the collaboration
of an overarching Patient Advisory Committee (PAC). In its entirety, the DICE Core will assume a pivotal role
in equipping investigators aligned to NIAMS-mission and the BIGDATA subtheme of community
engagement with the skills, assets, and virtual mechanisms to propagate research discoveries effectively as
well as amplify patient involvement in RMD research. As we pursue the aims outlined by the DICE Core, we
are dedicated to being responsive to the specific needs of patient populations living with RMD. We aim to
bridge the gap between research and practice, to improve outcomes in RMD research.